Enhancing Clinical Research Data Interoperability, Submission, and Sharing with Embedded Electronic Case Report Form Standards Mapping

Project Summary
Within the clinical research arena, investigators are increasingly expected to share their research data.
Enhanced data sharing can enable collaboration and reuse to achieve more scientific goals from the same or
decreased funding. Harmonizing disparate datasets can be a challenging and time-consuming process for
investigators. Therefore, applying a common data standard as part of the data sharing process can have
downstream benefits and efficiency gains. Additionally, investigators conducting regulatory clinical trials must
submit study data to the Food and Drug Administration (FDA) following the Study Data Tabulation Model
(SDTM) data standard developed by the Clinical Data Interchange Standards Consortium (CDISC).
Transforming data from case report forms into a common data standard, such as SDTM, is a resource-
intensive process. Up until recently, SDTM dataset preparation has been performed mostly by industry
sponsors and clinical research organizations who have sufficient resources to be able to handle this work.
However, a growing number of investigator-led studies have FDA submission or National Institutes of Health
Data Sharing Policy requirements. Researchers at academic medical centers are finding themselves in a
position where they have neither the expertise, nor the resources to prepare SDTM datasets. REDCap is an
electronic data capture system that is available at no cost to academic and non-profit institutions and is in use
at over 7600 organizations around the world. Since REDCap is already used by academic researchers for data
collection and dataset preparation, we hypothesize that a method to map REDCap case report form fields to
SDTM data elements will increase the accessibility and uptake of SDTM among academic research
organizations by greatly reducing the associated burden. Through the REDCap Standards Mapper
(REDSTAMP) project, we aim to 1) develop a coding structure and user interface for researchers to associate
REDCap fields to SDTM, and 2) apply the REDSTAMP method to existing International Maternal Pediatric
Adolescent AIDS Clinical Trial Network (IMPAACT) studies and CDISC foundational case report forms. We will
demonstrate the effectiveness of this method by comparing the SDTM datasets generated by REDSTAMP with
those originally produced for those studies by traditional methods. Both the REDSTAMP software and the case
report forms with embedded SDTM mapping will be published and shared through REDCap Consortium
platforms where researchers can import both directly into their projects. By developing a method where
researchers are guided through preparation of a SDTM dataset and can share the mapping with other
researchers, this project can promote awareness and expertise for clinical trials data standards. The collective
ability to map data to standards will improve the efficiency of regulatory submission and the interoperability and
reuse of shared clinical trials data.

Public health relevance
Project Narrative / Lay Statement Data from clinical trials funded by the NIH are often difficult for other researchers to reuse and regulatory agencies such as the Food and Drug Administration (FDA) to analyze because they do not conform to a standard format. This project seeks to create and apply methods that guide researchers through associating case report form fields with a standard format called the Study Data Tabulation Model (SDTM). The resulting tool will be embedded in software that researchers already use for electronic data capture and will improve the efficiency of preparing data for regulatory submission, and the interoperability of study datasets for sharing, aggregation, and reuse.